Microbiome-Mediated Tumor Immunomodulation in a Pathomimetic Colorectal Cancer Chip

ABSTRACT
Immune checkpoint inhibitors (ICI) have demonstrated notable efficacy in various cancers, yet the majority of
colorectal cancer (CRC) patients with mismatch repair-proficient (MMR-p) and microsatellite-stable (MSS)
tumors do not respond to ICI-based immunotherapy. Recent research suggests that the gut microbiome may
influence the outcome of ICI-mediated cancer immunotherapy in certain cancers. However, the precise
molecular mechanisms underlying the immunomodulatory tumor-microbiome crosstalk and its impact on tumor
immune checkpoint molecules (ICM) and immunotherapy outcomes in unresponsive tumors remain poorly
understood. In this proposal, we aim to profile patient-specific tumor-microbiome interactions and conduct
quantitative molecular analyses to elucidate microbiome-mediated modulation of ICMs in MMR-p MSS colorectal
tumors. We will utilize patient-derived tumors or normal organoids in a pathomimetic CRC Chip model. Our
overarching goal is to provide a strategic roadmap and personalized workflow to enhance immunotherapeutic
effects on non-responsive colorectal tumors by quantitatively assessing and robustly validating various tumor-
microbiome interactions. Preliminary studies from our NCI IMAT R21 program (R21CA236690, completed) have
demonstrated that patient-derived tumor or tumor-adjacent normal organoids can verify a patient's pathological
characteristics. We have also established 3D tumor microenvironment and tumor-microbiome co-cultures in a
Gut-on-a-chip platform, showing that co-culture with Bifidobacterium adolescentis substantially reduces PD-L1
expression on MMR-p MSS colorectal tumors, followed by CTL-mediated tumor eradication in a CRC Chip. In
this project, we will conduct cellular and molecular phenotyping of tumor ICMs under tumor-microbiome
interactions (Aim 1), examine microbial immunomodulation on normal epithelium adjacent to tumors (Aim 2), and
validate microbiome-mediated ICM perturbations in the presence of paired fecal microbiota (Aim 3). We envision
that our personalized pre-clinical CRC Chip model will have translational and transformative impacts, as the
expected outcomes can generate implementable databases reflecting patient genetics, demographic impact,
quantitative molecular phenotyping, and improved responsiveness to immunotherapy.

Public health relevance
PROJECT NARRATIVE The vast majority of CRC patients with MMR-p and MSS tumors do not respond to ICI immunotherapy, with over 95% showing unresponsiveness. To tackle this challenge, we propose a patient-derived CRC Chip model combined with quantitative molecular analyses to explore the microbiome's influence on ICI modulation in unresponsive tumors. Through this approach, we aim to provide a mechanism-driven translational impact, considering genetic, sociodemographic, and microbial factors, to enhance our understanding of immunotherapeutic responsiveness.